Biomechanical and Biological Predictors of Cartilage Health Following Meniscus Injury

Abstract for Parent Grant AR079184
Injury of the meniscus is frequently associated with early onset osteoarthritis (OA). Partial meniscectomy to
remove the damaged meniscal tissue is the most commonly performed orthopaedic procedure. While this
procedure can provide symptomatic relief in the short term, nearly 35% of patients develop radiographic evidence
of OA within 5-7 years following surgery. However, the causes for this early onset OA are unknown. One potential
pathway for the progression of knee OA following meniscectomy is through altered loading of the articular
cartilage. However, other studies suggest that biological factors, such as joint inflammation may play an
important role. Recently, through a combination of MR imaging, 3D modeling, and biplanar radiography, our
team has shown that medial meniscal injury alters the cartilage-to-cartilage contact strains in both the medial
and lateral compartments. In addition, we found that increased strain was correlated with increased levels of
matrix metalloproteinase (MMP) activity in the synovial fluid, a biomarker which may be indicative of joint
degradation. Together, these results suggest that biomechanical and biological factors play an important role in
the development of OA after meniscal injury. However, the role of partial meniscectomy on these changes is
unclear. Thus, a comprehensive evaluation of the biomechanical and biological environment of the joint before
and after partial meniscectomy will elucidate the factors that contribute to early onset OA. Our overall
hypothesis is that following partial meniscectomy, both biomechanical and biological changes in the
joint will predict cartilage degeneration. Furthermore, when biomechanical and biological predictors are
combined together with patient demographics and clinical characteristics, we will identify well-defined
clinical phenotypes of patients at high risk of cartilage degeneration.
Cartilage degeneration will be assessed through MR-based measures of cartilage thickness and
composition. Using high speed biplanar x-ray and MR imaging, in vivo cartilage strains in both knees of patients
with unilateral medial meniscus injury will be measured in response to treadmill walking prior to surgery and after
surgery. Synovial fluid and serum will also be collected and a panel of pro-inflammatory mediators and tissue
metabolic biomarkers will be measured. Synovial fluid immune cell analyses will be performed by flow cytometry.
Using these biomechanical and biological factors, we will identify participants at increased risk for cartilage
degeneration at two years after surgery. Then, using predictive models combining biomechanical factors,
biological factors, demographics, and clinical characteristics, we will develop well-defined clinical phenotypes of
cartilage degeneration risk. Importantly, the development of these phenotypes will enable targeted treatment
approaches focused on surgery, pharmaceutical targets, and non-pharmacological interventions, such as
physical rehabilitation strategies or weight loss, to prevent cartilage degeneration.

Public health relevance
Project Narrative for Parent Grant AR079184 Meniscus injuries are very common and frequently lead to early onset osteoarthritis, a leading cause of disability. This project will identify biomechanical and biological predictors of cartilage degeneration after meniscus injury and partial meniscectomy. Our findings will be utilized to improve care and outcomes for patients suffering from meniscus injuries.